Administrative Core

PROJECT SUMMARY
Administrative Core
The Administrative Core is responsible for the overall leadership, management, and execution of the
ROBIN center, and it will provide overall organizational, administrative, scientific and clinical management. The
Administrative Core will oversee and coordinate all ROBIN program components and centrally monitor and
evaluate their performance. In addition, the Administrative Core will facilitate all interactions with the External
Advisory Board (EAB), the Steering Committee, and the other sites of the national ROBIN program. This
ROBIN center involves 3 institutions (Cleveland Clinic, Emory University, and Case Western Reserve
University), with multiple enrollment sites (Cleveland Clinic system, Cleveland Clinic Florida system, Emory
University system) across 2 NCI-designated Comprehensive Cancer Centers (Case Comprehensive Cancer
Center, Emory Cancer Center), with representation across these institutions as project and core leaders. The
Administrative Core personnel will be led by Drs. Chan, Yu, and Scott, with collaboration from the trial and
project leads. Both Drs. Chan and Yu (ROBIN PIs) have extensive experience in managing multi-institution
clinical trial and laboratory-based research programs. The specific aims for the Administrative Core are as
follows. In Aim 1, the Core will provide all organizational, administrative, educational, and scientific
coordination for the ROBIN center projects and cores by cultivating and promoting the ROBIN team through
innovation and excellence, collaboration, leveraging resources, and providing constructive feedback.
In Aim 2, the Core will provide centralized administrative management for all fiscal aspects of the ROBIN
center, including but not limited to clinical trial execution, accounting of grant funds, progress reports,
communication, meeting scheduling and minutes, and manuscript and grant preparation. In Aim 3, the Core
will evaluate research progress through oral and written documentation, with regular input from the EAB,
Steering Committee, and National Cancer Institute (NCI) leadership to ensure that each project meets its
objectives within the proposed time frame and to facilitate interactions with other ROBIN sites for trans-ROBIN
center projects. In Aim 4, the Core will ensure integration across ROBIN components, including projects and
cores, across all sites, and provide interaction through scientific exchanges, coordination of an annual scientific
retreat, and through training and development plans that will ensure state-of-the-art practices. In Aim 5, the
Core will ensure and monitor best practices for human subjects and animal research for all ROBIN center
projects and cores as well as clinical and data operations, and to ensure adequate human and animal
biospecimens for all projects (with the Translational and Clinical Correlates Core).